Systems and methods for molecular dissection of socio-environmental effects on aging

Project Summary
Despite extensive research on the relationship between early-life social and physical environmental exposures,
and consequent effects on aging, little is understood about the mechanisms that link social interactions and
aging. The work proposed here provides technological, conceptual, and analytical innovations to fill this gap.
The R61 phase of our proposal will build on our existing technologies, which precisely measure how groups of
the fruit fly, Drosophila melanogaster, interact with each other as well as with their surroundings, to
accommodate long-term, longitudinal studies of aging individuals. Key components of our system will
include: (i) our DTrack video tracking system, which provides detailed and near-continuous quantification of
changes in movement, exploration, and social interactions, and (ii) our FLIC system, which measures each fly’s
interactions with food every 50ms and allows us to analyze the fine structure of feeding activities in real time.
These behavioral monitoring systems will interface with external Smart control modules that provide
programmable open- and closed-loop control of environmental variables, such as temperature and light, and
that will be coupled to genetic systems for acute manipulation of gene expression and neuron activity in
response to specific behaviors. During the R61 phase, we will also develop experimental and statistical tools to
analyze high-dimensional -omic profiles, which will be used to identify molecular mechanisms that shape and
are shaped by social interactions and aging. A series of Goals and Milestones will ensure that this new
technology supports the requirements for long term husbandry and that it is robust, reliable, and effective for
detecting reasonable differences in behavioral profiles among individuals and groups of individuals. The R33
component of our proposal will use these tools to provide the first detailed characterization of age-dependent
socio-environment interactions in an influential model system for aging research, and we will evaluate their
association with mechanisms of slowed aging. Importantly, our research will also begin dissecting the
mechanisms underlying how aging modulates social interactions and how these interactions modulate aging.
We will accomplish this by exploiting our ability to dynamically stimulate and inhibit individual neurons in
live, behaving animals to identify the molecular mechanisms through which behavioral interactions influence
lifespan and to evaluate behavioral and molecular interventions that reverse the deleterious consequences of
adverse social conditions. Measures of resilience in metabolome profiles will enable us to link relationships
between social interactions and aging to specific functional cellular pathways. The technology and
experimental paradigms that we develop will push the limits of behavioral monitoring and analysis in any
organism, will offer the first glimpses of mechanisms through which behavioral interactions influence aging in
Drosophila, and will provide a foundation for future investigation in other species, including humans.

Public health relevance
Project Narrative We will build on sophisticated technology that we have invented to measure how groups of animals interact with each other as well as with their surroundings during long-term, longitudinal studies of aging, and how these interactions affect demographic and molecular measures of health. These new technologies and experimental paradigms will push the limits of behavioral monitoring and analysis in any organism and will be used to investigate the molecular causes and consequences of social interactions on aging.